Identifying Challenges and Opportunities for PrEP Uptake Among Women at Elevated HIV Risk in Georgia

In Georgia, preventing HIV infection among women at high risk poses significant challenges. Despite the
availability of Pre-Exposure Prophylaxis (PrEP), the current system's requirement for women to visit specific
AIDS centers creates a substantial barrier to access. This proposed study aims to build upon the parent grant's
goals to establish an HIV implementation center in the Caucus region by addressing the research gaps in
women's preferences for PrEP delivery. The focus will be on partners of people who inject drugs, women who
inject drugs, sex workers, and transgender women residing in Tbilisi and Batumi, with a total sample size of 540
women. The recruitment strategy will involve social workers from HIV prevention services, such as needle and
syringe programs and methadone therapy centers, as well as peer workers from partner organizations. The
study will employ a combination of focus groups (with 40 women) and computer-assisted personal interviewing
(with 500 women) using a choice-based conjoint approach. This methodology will explore key aspects of PrEP
delivery that are most important to women, including location, eligibility screening, and adherence support. The
insights gained from this study will be used to design a more women-friendly and accessible PrEP program. The
ultimate goal is to increase the involvement of women at elevated risk of HIV in PrEP, thereby enhancing the
effectiveness of HIV prevention efforts in Georgia.

Public health relevance
Currently, Georgia struggles to reach women at high risk of HIV with PrEP, a powerful preventive intervention. This pre-implementation project employs nominal group technique focus groups and a choice-based conjoint approach to survey women with elevated HIV risk—including partners of people who inject drugs, women sex workers, transgender women, and women who use drugs—to understand barriers and preferred delivery methods for PrEP. The goal is to design a more accessible and women-friendly program that empowers these women to protect their health and remain HIV-negative.